Core A: Tissue and Pathology Core

TISSUE AND PATHOLOGY CORE: SUMMARY/ABSTRACT
The Tissue & Pathology Core will coordinate efforts related to collection, processing, storage, and distribution
of annotated human and murine biospecimens for all of the MD Anderson Sarcoma SPORE projects, including
the projects from the Developmental Research Program (DRP) and Career Enhancement Program (CEP)
awardees. The Core will be co-led by Alexander J. Lazar, M.D., Ph.D. and Wei-Lien (Billy) Wang M.P.H., M.D.,
two nationally reputed sarcoma pathologists with over a decade of close collaboration. The Tissue &
Pathology Core will work with all SPORE Projects (including DRP and CEP projects), CCSG Cores,
collaborator laboratories, and with the Administrative and Biostatistics & Bioinformatics Cores, to ensure
maximum efficiency of tissue/derivatives. The Core will provide optimization of fresh tissue collection, analyte
(DNA, RNA, protein) extraction from prospectively collected and archival tissue samples suitable for molecular
and immunological interrogation, and the conduct of NanoString gene expression profiling. The samples and/or
analytes isolated from biospecimen will be distributed to SPORE Projects and other investigators in
accordance with Core operating procedures. Existing sarcoma biospecimen resources available in institutional
tissue banks include snap frozen tumor tissue samples from over 4,000 sarcomas, with about 30% of these
directly relevant to the SPORE Projects. Formalin fixed paraffin embedded specimens are available for over
8,500 sarcoma cases over just the last 15 years, including tissue microarrays from 15+ sarcoma types
(4,000+ cases arrayed). In addition, the Core will provide histologic characterization, immunohistochemistry
services, and interpretation guidelines for both preclinical samples from the mouse model studies in Projects 2
and 3, as well as serial human tissue biopsies obtained from the two clinical trials being conducted in Projects
2 and 3. Blood will also be processed for flow cytometry and exosome isolation in Projects 2 and 3. The Core
will support Project 1 by providing expert pathological assessment of tissue samples used for whole genome
studies as well as technical support for extraction of DNA from tissue and blood samples and submission to
appropriate sequencing platforms. The Core will coordinate distribution of appropriate samples to investigators
funded through the SPORE CEP and DRP. Core personnel, along with the Institutional Tissue Bank, will enter
detailed information related to all processes of biospecimen collection, processing, qualification, distribution,
and analyte extraction into the institutional biospecimen informatics platform known as Biospecimen
Information Management System (BIMS™). This centralized resource will contribute significantly to the
success of the multidisciplinary and translational research projects outlined in this proposal.